Membrane properties of cells comprising the OHC system

DESCRIPTION (provided by applicant): The organ of Corti is composed of a variety of cell types including sensory, supporting and neural elements. Taken together, these cells comprise a functionally intricate and cohesive electrical unit that initiates the analysis of acoustic information within our environment. This electrical unit is extremely complex and nearly anatomically inaccessible, making an analysis of the whole quite a challenge. Fortunately, during the last several years the in vitro approach, including the isolated cochlea and cell preparations, has aided in the elucidation of cell function; the strategy is to understand the cells first on an individual basis, and finally to integrate this knowledge into a complete understanding of the organ of Corti. The overall aim of this project is to analyze the membrane properties of the outer hair cell (OHC), one of the major players in auditory function, principally using variations on the whole cell voltage and current clamp technique. We intend to 1) study characteristics of the OHC membrane that may impact on its motor performance, 2) study the chloride dependent allosteric modulation of the OHC motor and 3) study the developmental changes in the motor's biophysical sensitivities. I believe that the timely evaluation of these three specific research aims will help us appreciate key elements contributing to peripheral auditory system performance.

Public health relevance
PUBLIC HEALTH RELEVANCE: With the identification of prestin as the elusive lateral membrane motor protein of the outer hair cell (OHC), we are faced with the possibility of understanding how this single molecule can affect the mammal's exquisite sense of hearing. To that end, we have focused our interest on determining how allosteric modulation of the motor may give rise to the motor's known biophysical attributes, and how the motor matures during development. We hypothesize that understanding these molecular activities will aid in understanding how the OHC enables us to hear so well and in turn how we might combat pathologies of the OHC that afflict millions.